Project 2: Thymic and peripheral Aspects of T cell Aging and Rejuvenation

PROJECT 2: RESPONSE OF THE AGED THYMUS TO INJURY AND REJUVENATION ABSTRACT Even though the thymus is is exquisitely sensitive to acute injury such as that caused by infection, shock, or common cancer therapies such as cytoreductive chemo- or radiation therapy, it also has a remarkable capacity for endogenous repair. However, this capacity declines with age and is a major clinical hurdle in elderly patients who receive an immune insult such as that caused by common cancer cytoreductive therapies and the conditioning required for hematopoietic stem cell transplantation (HSCT). The premise of this project is that the thymic regenerative response to acute injury is weakened with age and correlates with age-related thymic involution. We will compare and contrast what we know about the cellular and molecular pathways that underpin thymic regeneration in young animals, to the regenerative response in mice during normal thymic aging; and develop rational intervention strategies to improve regeneration in aged mice. In this project, we will comprehensively assess the endogenous regenerative response over lifespan (SA1), perform studies to better understand the underlying mechanisms governing endogenous thymic regeneration and their breakdown in aged mice (SA2), and test known and putative strategies to determine their effectiveness in promoting thymopoiesis in aged tissue that has undergone damage (SA3). Our project has multiple points of interaction with the other projects and cores of this P01, including providing the basis for exploring the role of endothelial cells (ECs) and BMP4 in thymic and SLO aging. Together, these aims support the overarching goal of the P01 to identify the mechanisms responsible for defects in thymic production of naïve T cells with age. The mechanistic and pre-clinical studies outlined have the potential to define important novel pathways underlying thymic regeneration, which could result in clinical approaches to enhance T cell immunity in patients whose thymus has been decimated due to age-related involution.